Microarray

The OSUCCC Microarray Shared Resource (MASR) was established as a

Public health relevance
The Microarray Shared Resource (MASR) offers unique, cost-effective, and timely technical and professional expertise that promotes high-quality science. Services include: timely experimental design consultation, genome wide expression and SNP/mutation analysis on microarray and on nextgeneration instrumentation, array comparative genomic hybridization (CGH) assessment of DNA and RNA integrity, quantification of DNA and RNA, design, fabrication and validation of custom microarrays, quality sample processing, hybridization, and scanning. Outstanding institutional support allows the MASR to contribute to cutting edge-cancer research that integrates OSUCCC investigations across the entire University, state of Ohio, and nationally with multiple NCI Cancer Centers.